Imaging the Respiratory Effects of Truncal Adiposity in Acute Hypoxemic Respiratory Failure

PROJECT SUMMARY
Obesity affects more than 40% of the United States population and is a major risk factor for acute hypoxemic
respiratory failure (AHRF). AHRF patients with obesity have more ventilator-related morbidity and may be less
responsive to standard respiratory care treatments, such as prone position and positive end expiratory pressure
(PEEP) titration, compared to patients of normal body weight. Excess truncal adiposity in obesity elevates
intrathoracic pressure (ITP) and compresses lung tissue. Our prior research has shown that obesity also modifies
ventilator-induced lung stretch. In addition to the mass of adiposity, published and preliminary data suggest that
the distribution of adiposity influences ITP and may affect the magnitude and pattern of lung collapse. Imaging
the topographic effects of truncal adiposity on lung tissue may therefore 1) provide insight into AHRF severity
and treatment response in obesity and 2) identify viable tools that can quantify the effects of truncal loading at
bedside. Our research group has extensive expertise in applying novel computed tomography (CT) image
analysis involving registration and artificial intelligence-based segmentation to quantify lung collapse and injury
progression in AHRF. In this proposal, we will use CT to test our hypothesis that the magnitude and distribution
of truncal adiposity governs lung collapse and severity of AHRF in obesity. Using CT as reference, we will further
evaluate how measurements of ITP (esophageal manometry), global respiratory mechanics (forced oscillation
technique), and regional ventilation (electrical impedance tomography) can detect the effects of truncal loading
on lung collapse at bedside. To achieve the aims of this proposal, we have developed a ventilated swine model
of AHRF and a robust clinical infrastructure to monitor patients with AHRF in our hospital. We will first measure
in our animal model the effect of load distribution on imaging, biological, and physiological markers of AHRF
progression during prolonged mechanical ventilation for 24 hours. We will then evaluate the effects of prone
positioning and PEEP titration on the regional inflation characteristics and radiological abnormalities using
sequential imaging in conditions of truncal loading. Lastly, in ventilated patients with AHRF and in healthy
volunteers with and without obesity, we will measure associations between thoracic adiposity, ITP, and lung
collapse in supine and prone position. Data obtained from our proposal will advance our understanding of obesity
in AHRF, informing individualized clinical management to assist in the early identification and treatment based
on the morphological and biomechanical characteristics of each patient.

Public health relevance
PUBLIC HEALTH RELEVANCE Obesity increases the risk of severe acute hypoxemic respiratory failure (AHRF) and alters responses to standard treatment. Excess adipose tissue imposes compressive forces on the lungs that may influence physiological and biological abnormalities in AHRF. Leveraging advanced imaging, the proposed research will elucidate how obesity contributes to AHRF severity and help optimize bedside instruments to identify abnormal loading conditions that may guide treatment in patients with obesity.